Administrative Core

The overall goal of the administrative core is to provide scientific and technical guidance for the
development and operation of the beamlines, provide administrative services for ongoing operation of the
NE-CAT, and oversee an active user program for both on-site and remote access. The administrative core
also oversees the development of RAPD, NE-CAT’s automated data collection and analysis software,
supports the NE-CAT website, and interfaces with APS, ANL, and DOE. NE-CAT’s administrative structure
has evolved over the past 20 years into a highly cohesive and effective group. The NE-CAT Director, Dr.
Steven Ealick (50% effort), has 30 years of experience in overseeing the development and operation of
synchrotron beamlines. Dr. Ealick resides in Ithaca, NY, and travels to the Advanced Photon Source about
once a month. Dr. Malcolm Capel is the NE- CAT Deputy Director (20% administration) and is responsible
for the day-to-day operation of the NE-CAT beamlines. The remainder of his effort is devoted mostly to
beamline maintenance and improvements. Dr. Frank Murphy is NE-CAT Associate Director (20%
administration). He oversees the user program and maintenance and development of RAPD, and the
remainder of his effort is devoted to user support, user training, and outreach. The three-person
management team is assisted at the APS by Ms. Cyndi Salbego, who administers the user program, NE-
CAT website, and is responsible for interfacing with the Department of Chemistry and Chemical Biology,
College of Arts and Science, and Cornell University infrastructure and for organizing, data gathering, and
reporting. The remainder of the NE-CAT staff comprises seven staff scientists and two technicians at APS,
and a staff scientist in Ithaca. The administrative core describes staff responsibities, including the temporary
reassignment of effort during the 12-month period without X-rays required for the APS upgrade.
Responsibilities during this period will be adjusted to aid in the rebuilding of our nearly 20-year-old
beamlines. NE-CAT receives regular input from the NE-CAT External Advisory Committee and the NE-CAT
Executive Committee. The Administrative Core is responsible for allocating beamtime, which is coordinated
with the APS Users Office, for scheduling users, and for ensuring that APS safety protocols are followed.
The Administrative Core is responsible for collecting and reporting metrics that demonstrate impact of the
resource. These include monitoring beam time usage, number of users, number of groups, user funding
sources, and level of demand for NE-CAT beamlines. Productivity is measured by publications and PDB
entries resulting from NE-CAT data. Finally, the Administrative Core is responsible for monitoring training
and dissemination activities, and for evaluating and promoting workforce and user diversity.